Experimental Models

Experimental Models (EM) module
Summary
The purpose of the Experimental Models (EM) Module is to provide expert service and
assistance for a large variety of in vivo testing and procedures, help facilitate all experiments
using animal models performed by MVRC investigators, and to enable them to develop new
interdisciplinary projects. Specific Aims are: 1) To provide expert services and assistance,
through the use of specialized equipment and experienced personnel, for a large variety of
surgical and non-surgical procedures for experimental vision research in mice, rats, rabbits,
cats, dogs, pigs and non-human primates, 2) To provide training to all investigators on
established procedures and assist investigators developing new procedures, including new
surgical methods and drug delivery, 3) To serve as a resource center for fostering new
collaborations among MVRC scientists and clinicians, and for sharing animal models, biological
tissues and genotyping protocols, 4) To consult and assist with IACUC and IBC protocols,
including protocol writing and compliance. Experienced personnel and specialized equipment
are available in this module for vision researchers. This module is essential for numerous basic
science and translational research studies at BPEI, as indicated by its extensive use by most of
our NEI-funded investigators. In the last funding period, the EM module was used to generate
data that was reported in numerous publications and included in new grant awards.
Furthermore, this module has been essential in developing novel electrophysiological and
behavioral assessment of vision in rodents, for creating inducible animal models of glaucoma,
traumatic optic neuropathy, retinal ischemia, diabetes, and macular degeneration, testing novel
gene therapies, and investigating environmental influences on animal models of retinal disease
through the use of the rodent smoking machine and specific nutrition modifications. This module
will continue to provide an essential resource for cutting-edge research by MVRC investigators.